GFR AND RPF DURING THE MENSTRUAL CYCLE

To determine if there are significant changes in Glomerular Filtration Rate (GFR) and Renal Plasma Flow (RPF) during the menstrual cycle, and if there is a correlation between menstrual cycle changes in GFR and RPF and hormonal functions which potentially modulate renal hemodynamics.